Cortical information loss in diffuse low-grade glioma infiltrated cortex

Project Summary/ Abstract.
Glioma, the most common primary brain tumor in adults, is a major cause of neurological morbidity and
mortality, with no effective therapies. Low-grade gliomas invade healthy brain tissue over decades and as a
result fundamentally alter cellular and circuit level interactions responsible for information processing. As a
result, nearly all patients experience cognitive and behavioral impairments. New treatments have been
obstructed by limited understanding of the cellular and circuit level mechanisms governing the integrity of
neural circuits following low-grade glioma infiltration.
The influence of glioma infiltration on neuronal circuits have traditionally assumed that neurological
impairments occur because of glioma induced neuron death. However, it is now known that tumor cells make
electrical and chemical synapses with excitatory glutamatergic neurons. Neuronal signaling within cognitive
networks are however both balanced synchrony between excitatory and inhibitory signals and directional,
enabling the transmission of information to be organized in a hierarchy. The extent to which whether low-grade
gliomas cortical infiltration influences cortical laminar structure and GABAergic inhibitory signals remains
incompletely studies. This knowledge gap contributes to a paucity of therapies. Our long-term goal is to
accelerate the development of precision-medicine therapies to treat cognitive impairments through the
modulation of neuronal inputs. The objective of this application is to determine how glioma infiltration
influences cortical structure and function. The central hypothesis is that inhibitory GABAergic inputs are
reduced within lower feedback layers of cortex (Aim 1). Furthermore, we propose that information processing
of sensory representations (Aim 2) and speech production (Aim 3) will be demonstrated as loss of neuronal
population tuning responses which may be recovered with GABAergic restoration.
Aim 1 will define the cortical neuron laminar structure and excitatory-inhibitory transcriptional programs of
glioma-infiltrated cortex using histology and spatially resolved transcriptomics for neuronal density and subtype
within each cortical layer. Aim 2 will determine the functional consequences of glioma infiltration on information
processing in sensory regions. High-density local field potentials will be recorded from superior temporal and
somatosensory regions during speech perception and tactile tasks, examining task-related changes in
neuronal responses. Aim 3 will identify the functional consequences of glioma infiltration on information
processing in higher-order speech and motor regions. To do so, we will measure the spatial and temporal
responses from ventral pre-motor and motor regions to five clinically administered language paradigms of
varying complexity. We expect this work to advance understanding of information loss in low grade glioma.
These results will motivate and clarify potential target mechanisms for future clinical trials focused on restoring
excitatory-inhibitory balance to treat patients.

Public health relevance
Project narrative. Low-grade gliomas are tumors originating in the young adult brain and patients experience many years of survivorship without active disease. Most patients experience impaired cognition which limits social, vocational, and emotional health. These studies will offer deeper and new therapeutic insight into understanding how gliomas disrupt information processed in the brain and suggest new approaches to their treatment.